Development of Specific Mu Opioid Receptor Antagonists to Reverse the Acute and Chronic Toxicity of Fentanyls

Project Summary
This proposal is in response to PAR-20-092: Development of Medications to Prevent and Treat Opioid Use
Disorders and Overdose (UG3/UH3) (Clinical Trial Optional). We propose to develop novel MOR antagonists
carrying 1-phenethyl-N-phenylpiperidin-4-amine skeleton to effectively and specifically reverse the acute toxicity
of fentanyl and its analogs. The fentanyls are a large family of synthetic opioids and are prominent on the list of
opioid abuse and addiction due to the fact that some of them are up to 10,000-fold more potent than morphine.
Because of their high potency and longer half-life than naloxone, the front-line treatment for fentanyl overdose,
multiple infusions and high doses of naloxone may be required during reversal procedure. Another fentanyl
addiction treatment, naltrexone, has been reported with patient non-compliance and unwanted side effects.
Recently we have identified a novel molecular mechanism of fentanyl binding and activation on its target protein,
the MOR, through systematic computational chemistry and biochemistry studies. More importantly, we identified
a new fentanyl derivative, phenylfentanil, as a potent antagonist of the MOR. Phenylfentanil shares the same
structural skeleton, i.e. 1-phenethyl-N-phenylpiperidin-4-amine, with fentanyl. It carries reasonably high affinity
to the MOR and acts as a neutral antagonist on the receptor based on recent studies. Accordingly, we plan to
apply these findings to further characterize phenylfentanil and its derivatives with similar pharmacological
characteristics both in vitro and in vivo, and pursue preclinical development on these leads as novel reversal
agents against the acute toxicity of fentanyl. In the UG3 phase, we plan to pursue two specific aims in order to
define novel leads with reasonable potency and pharmacokinetics profiles as fentanyl reversal agents while in
the UH3 phase, we propose to conduct IND-enabling studies on the most promising candidate and eventually
file an IND with the FDA by the end of the funding period.

Public health relevance
Project Narrative Fentanyl and its analogs are a group of synthetic opioids that may be 100-10,000 times more potent than morphine. Overdose of these opioids is extremely dangerous due to their ultra-potency and high fatality rate while current treatments may not be as effective as expected considering their moderate potency and unwanted side effects. Here we propose to develop novel mu opioid receptor antagonists to specifically counteract fentanyl and its analogs, and to reverse their acute toxicity more effectively with fewer side effects.